Mitochondrial malfunction perturbs lysosomal activities and cellular nutrient sensing pathways

PROJECT SUMMARY
The hallmarks of aging are well established, and include mitochondrial malfunction, deregulated nutrient sensing,
altered inter-cellular communication, and senescence, among others. These hallmarks have typically been
studied independently, and it is unclear how they are coordinated. It remains poorly understood, particularly in
mammals, how mitochondrial malfunction relates with the other hallmarks of aging. We have found that
mitochondrial malfunction can affect lysosomal membrane composition, which in turn impacts lysosomal activity,
and our preliminary data show that the combined effect of mitochondrial malfunction and lysosomal impairment
perturbs nutrient sensing and inter-cellular communication through the secretion of cytokines akin to the
senescence-associated secretory phenotype (SASP). Notably, the SASP-like signature is detectable long before
senescence markers and is fully reversible. Therefore, we hypothesize that mitochondrial malfunction and its
impact on mitochondria-lysosome crosstalk can trigger other cellular aging hallmarks thus unleashing a
coordinated program of cellular aging.
To test this hypothesis, we will first test how mitochondrial contents can be sensed by the lysosomes, and how
different mechanisms of delivery of those contents impact the SASP-like signature. We will then test how the
SASP-like signature triggers senescence via paracrine signaling. Next, we will test how lysosomes modified in
response to mitochondrial malfunction cause aberrant nutrient signaling, and how this feature further contributes
to SASP-like signature and senescence, both in vitro and in vivo. Finally, we will test how the changes in
lysosomal membrane composition affect the physical contact sites between lysosomes, mitochondria and
endoplasmic reticulum, and how this organelle rearrangement contributes to the aging phenotypes.
Through this work, we will harness the mechanisms mitochondrial malfunction and the consequent lysosomal
impairment trigger multiple aging hallmarks in a coordinated manner, through mechanisms that provide a window
of opportunity for therapeutic interventions. These results are directly relevant to a more complete understanding
of the processes leading to cellular and organismal aging in humans and other mammals.

Public health relevance
PROJECT NARRATIVE The hallmarks of aging are well established, and include mitochondrial malfunction, deregulated nutrient sensing, loss of proteostasis, and senescence, among others. While these hallmarks are all part of the aging process, they have typically been studied independently. We have found that mitochondrial malfunction can affect lysosomal activity, impacting nutrient sensing, and that the crosstalk between mitochondria and other organelles such as endoplasmic reticulum and lysosomes affects cellular senescence, proteostasis and intracellular communication. We propose to that the impact of malfunctioning mitochondria on lysosomes, and the altered mitochondria-lysosome crosstalk that follows, orchestrates multiple other aging hallmarks.